Metalloproteins: evolution, catalysis and material design

Project 1: Recently, we have demonstrated for the first time the predictive link between NMR chemical
shift perturbation, protein dynamics and probability of finding productive mutations, which allowed us to create
an unnatural metalloenzyme with with a 107-fold improvement over the background rate and less than 100-fold
away from the diffusion limit. I propose to expand NMR-guided directed evolution to 1) utilize other protein
dynamics probing modalities to aaply the approach to larger proteins; 2) develop catalysts for practically useful
reactions; 3) develop of metal-binding proteins with high metal affinity. Results generated in the proposed work
will help advance fundamental understanding of the principles that define function in metalloproteins and drive
enzymatic activity. From the practical standpoint, this work will allow for creation of smaller functional proteins
capable of promoting chemical transformations and produce inexpensive and biocompatible protein catalysts
that could be easily handled in the applied setting for pesticide/chemical weapons remediation, DNA hydrolysis
and phenol oxidation. Project 2: I will develop new approaches to osteoarthritis treatment using smart, stimuli-
responsive, self-healing biocompatible antimicrobial hydrogels. In addition to direct biomedical application of the
designed hydrogel materials, structural models for the hydrogel assemblies will facilitate our understanding of
the mechanism of gelation of metallopeptides and will guide rational design of improved materials.
1

Public health relevance
We will test the limits of our recently developed method of NMR-guided evolution and apply it 1) to proteins that cannot be easily characterized using NMR spectroscopy; 2) to design of highly active metalloenzymes for practically useful reactions and 3) to devlop metalloproteins with high metal affinities. I will also develop new approaches to osteoarthritis treatment using smart, stimuli-responsive, self-healing biocompatible antimicrobial hydrpogels.